Collaborative for REsearch to AdvanceTMD Evidence (CREATE)

Temporomandibular disorders (TMDs) involve complex and poorly understood
pathophysiological processes, limiting prevention, diagnosis, prognosis and the development or
application of effective, evidence-based treatments. The Collaborative for REsearch to Advance
TMD Evidence (CREATE) aims to address these critical gaps through a bidirectional approach
that integrates clinical and preclinical research to identify underlying mechanisms, develop
personalized therapies, and improve patient outcomes. The Administrative Core (AC) will
manage CREATE’s scientific, administrative, and operational functions, ensuring alignment with
NIH goals, standardizing data collection across sites, and adhering to FAIR principles for data
and biospecimen management. The Bioinformatics and Data Science Core (BDSC) will employ
the latest AI and machine learning techniques to analyze multi-modal data, identify TMD
subtypes, implicate therapeutic targets, and establish frameworks such as common data
elements (CDEs) and ontologies to enhance data integration. The Outreach, Training, and
Education Core (OTEC) will expand the TMD research and clinical workforce, foster
collaboration with stakeholders, and organize biannual public workshops to disseminate findings
and guide the Collaborative’s efforts. At the heart of CREATE is the Deep Pain Phenotyping
Project, a large-scale longitudinal study involving 1,000 TMD patients and 300 age-matched
controls across multiple US clinical centers, designed to enable identification of TMD subtypes
through standardized assessments and mechanistic deep phenotyping. The identification of
TMD subtypes with high reliability and selectivity will facilitate diagnosis and prognosis and
future clinical trials, and may suggest more effective preventive and therapeutic strategies. The
clinical dataset will also inform reverse translation to preclinical studies to further elucidate
mechanisms and validate therapeutic targets. By leveraging the expertise of a diverse,
multidisciplinary team, CREATE seeks to bridge the gap between clinical data and preclinical
insights, paving the way for improved diagnostics, treatments, and patient care in TMDs.

Public health relevance
Temporomandibular disorders (TMDs) are complex conditions that are not well understood, making it difficult to prevent or treat them effectively. The CREATE team brings together experts to study TMDs in detail, combining patient data and laboratory research to uncover causes, develop personalized treatments, and improve care for people living with these disorders.